Core--Clinical and administrative

DESCRIPTION: This core will provide leadership and administrative oversight for the program project. In addition, it will monitor the allocation of program funds and resources, conduct diagnostic and clinical assessment for the participants, and provide guidance for the design and statistical analyses of ongoing studies.